Cerebellum and Habit

Project Summary
Much of our behavior is habitual. Habits are defined as behaviors that are initiated automatically in response to
stimuli, which means that neural representations of the likely outcome of the behavior (e.g., a reward) do not
control these behaviors. The neural mechanisms underlying habit learning and performance are of clinical
relevance because compulsive disorders, such as obsessive-compulsive disorder and drug addiction, are likely
to involve imbalances between habit and goal-directed control over behavior. The most prominent theories posit
that stimulus-action associations – neural representations of the stimulus that activate the habit action – are
formed as a consequence of dopamine-mediated reinforcement learning and plasticity in corticostriatal circuits.
Although lesion, inactivation and pharmacology studies of the dorsal striatum support this view, there is little
neurophysiological evidence that dorsal striatal neurons represent stimulus-action associations.
Here, we propose a novel hypothesis: that habit learning is a form of skill learning that, like other forms of skill
learning, is dependent on sensory prediction error-based plasticity in the cerebellum. Skills are action sequences
that are performed rapidly and accurately. Like habits, performance of skilled action sequences does not require
a neural representation of the reward outcome (although skilled action sequences can be activated by such
representations). Skilled action sequence learning depends on adjusting ongoing and future actions based on
the difference between the action performed and the action predicted by the immediately-preceding action or
stimulus. These differences are represented as sensory prediction errors in the cerebellum and, during skill
learning, cerebellar output neurons come to represent action-action and stimulus-action associations. The
activity of these neurons produces accurate movements at the correct time within the sequence. We propose
that connecting a stimulus to an action sequence so that the action is performed automatically after stimulus
presentation – i.e., learning a stimulus-action habit – requires the same cerebellar circuitry and supervised
learning algorithm as learning the action sequence itself.
The proposed experiments test the strong predictions of this hypothesis that disruption of cerebellar function will
disrupt the formation and performance of stimulus-action habits, and that the firing of neurons in the deep
cerebellar nuclei will reflect the formation of stimulus-action associations. Furthermore, based on anatomical
studies that show reciprocal mono- and polysynaptic connections between the cerebellum and the infralimbic
cortex, a structure required for habit behavior, we will specifically investigate whether these projections contribute
to habit learning and performance. Establishing a role for the cerebellum in habit learning would be consistent
with a growing literature indicating that the cerebellum participates in cognitive functions far beyond motor
behavior. Most importantly, demonstrating a plausible candidate cerebellar mechanism for habit learning would
constitute a paradigm shift in our understanding of how habits are learned and controlled.

Public health relevance
Health Relevance Compulsive disorders such as obsessive-compulsive disorder, binge eating disorder, and addiction affect millions of Americans. These disorders are thought to involve inordinate control over behavior by the brain’s habit systems – neural circuitry that produces automatic responses to stimuli in the environment. This circuitry includes the dorsal striatum and sensorimotor cortex, but recent evidence indicates that the cerebellum – a structure that is essential for motor learning and behavior – may also contribute to both habit learning and compulsive disorders. The proposed experiments begin to test a novel hypothesis for the mechanistic role of the cerebellum in habit behavior.